Effectiveness of Adverse Community Experiences and Resilience (ACER) and Community Organizing for Preventing Youth Violence and ACEs.

PROJECT SUMMARY/ABSTRACT
Violence is one of several Adverse Childhood Experiences (ACEs) that can significantly impact children's
future physical and behavioral health. Different types of violence against youth, such as child abuse and
neglect and community youth violence, often share the same risk and protective factors. Community
disadvantage and disorganization are risk factors associated with community trauma and violence, which
can be addressed by community-level primary prevention strategies that emphasize community resilience
through community organizing. This study will evaluate Prevention Institute's implementation of the Adverse
Community Experiences and Resilience (ACE|R) community-level violence prevention framework,
responding to Objective 1: Effectiveness research to determine which community- or societal-level
strategies effectively prevent multiple forms of violence and other ACEs that impact children and
youth. More specifically, it has three aims: (1) retroactively measure the effectiveness of the ACE|R
framework implemented in Milwaukee on child abuse and neglect and youth violence using an idiographic
clinical trial approach; (2) prospectively test the comparative effectiveness of the ACE|R framework/
Milwaukee Blueprint for Peace with community organizing in four Priority Communities; and (3) use a Hybrid
Type 1 effectiveness-implementation design to explore the barriers and facilitators to implementing
community organizing within the ACE|R framework in a large metropolitan area (Milwaukee) to inform future
implementation efforts by determining strategies to address implementation barriers arising from (a) the
intervention characteristics, (b) outer and inner setting factors that shape implementation barriers and
facilitators, (c) individual characteristics among stakeholders that influence implementation barriers and
facilitators, and (d) strategies that facilitate implementation of community organizing within the ACE|R
framework. By addressing several factors associated with community trauma and violence, this framework
has the potential to prevent child abuse, child neglect, and youth violence. Findings will expand research
evidence for the facilitation of community resilience efforts and contribute valuable insight regarding
efficacious, practice-based violence prevention programming.

Public health relevance
PROJECT NARRATIVE This study will evaluate the Adverse Community Experiences and Resilience (ACE|R) framework for community-level violence prevention through economic, social, and place-based strategies to heal trauma in communities. We will test (a) whether this process has reduced rates of child abuse and neglect and youth violence over the past 4 years of its implementation in the Milwaukee Blueprint for Peace and (b) the benefits of adding community organizing focused on engaging and mobilizing community members to support strategies to prevent violence. Our findings will provide insight about the best ways to help neighborhoods and cities fight child abuse/neglect and youth violence.